Trafficking and function of macrophage subpopulations within the lung microenvironment during pneumonia

Pneumonia is a common disease and a frequent cause of morbidity and mortality. S. pneumoniae is the most
common cause of community-acquired pneumonia and a major health concern. Understanding lung host
defense in response to this organism and successful resolution of inflammatory and immune responses is
important and likely to have impact on novel ways to intervene therapeutically. Lung macrophages are a
critical arm of host defense in healthy lungs and in response to infection or any injury. The classification of
subpopulations is very topical and controversial. We have focused on macrophage categories designated by
surface markers that identify three subpopulations; alveolar macrophages (AMs), interstitial macrophages
(IMs) and inflammatory macrophages (InfMs). In unchallenged lungs, our preliminary studies show that AMs
are the only lavageable macrophage present in the airways/alveoli. Digests of PBS-treated (control) lungs
reveal that of total lung macrophages, about 28% are AMs, 50% are IMs, and 22% are InfMs. Gene profiling of
isolated subpopulations reveals very distinct patterns of mRNA expression by each subpopulation, suggesting
in health, each subpopulation has unique functions. During pneumonia, the percentage and number of each
subpopulation changes dramatically. Initially, the total number of lung macrophages increases 3-4-fold, which
reflects a decrease in the number of AMs, an increase in InfMs and no change in IMs. By 14 days, the
numbers are nearly back to those in healthy lungs, but AMs are now from both bone marrow and lung-resident
origins. Thus, these subpopulations are very dynamic and very likely to have specific functions that may
change within each subpopulation over the course of a pneumonia. Furthermore, these cell-specific changes
in number and function are very likely to be modulated by the alveolar microenvironment, which changes
during infection and the immune response. Our studies use lung-protected radiation and bone marrow
reconstitution that generates chimeric mice but does not alter the lung macrophage subpopulations. The Aims
test the overall hypothesis that subpopulations of lung macrophages each play specific and important roles in
host defense during bacterial pneumonia, with the expectation of identifying new and important mechanisms
underlying these processes. Aim 1 determines trafficking kinetics, including changes in the subpopulations of
lung macrophages during pneumonia and the mechanisms through which these changes occur. Aim 2
determines the function of each macrophage subpopulation. Aim 3 determines the effect of the alveolar
microenvironment on the kinetics and function of macrophage subpopulations. These studies test the
hypothesis that trafficking and function of particular subpopulations will be modulated by parenchymal ICAM-1,
by the CX3CL1/R1 (fractalkine) axis, and by Nrf2-mediated cytoprotection against oxidant damage.

Public health relevance
Project narrative: relevance of this research to public health Bacterial pneumonia is a particularly common and devastating public health problem that affects people of all ages and health status and is associated with a high morbidity, mortality and cost. The proposed studies address the ways in which we protect ourselves from bacteria within the lungs. The ways in which the different populations of lung macrophages respond to bacteria, destroy them, and then resolve the pneumonia will be studied, and new therapeutic approaches to balance this response toward healthy lung repair will be identified.